Cellular and circuit mechanisms enabling oxytocinergic control of pain defense

Project Summary
The neurotransmitter oxytocin (OXT) is well known for its social and reproductive roles, but has also gained
increasing attention as an endogenous regulator of the neural response to pain. Exposure to noxious stimuli
activates both neuroendocrine and centrally-projecting OXT-producing neurons in the mammalian
hypothalamus, and both populations have been shown to exert analgesic effects. Additionally, the centrally-
projecting group influences pain-related behaviors such as fear conditioning through targets in the piriform
cortex and the amygdala. While the ability of these cells to dampen the acute perception and long-term memory
of painful experience makes them highly relevant to the clinical treatment of pain disorders, post-traumatic
stress, and other conditions, very little is known about the cellular and circuit mechanisms by which
hypothalamic OXT neurons influence pain processing, or more generally how they might affect other pain-
related phenomena.
This project will exploit the experimental leverage offered by the larval zebrafish to investigate the means by
which OXT neurons enhance the sensitivity of a sensorimotor circuit to painful stimuli and promote defensive
behaviors. Our central model is that stimulus intensity is encoded by graded activity in a subpopulation of OXT
neurons which project onto and activate or sensitize spinal projection neurons (SPNs) through the differential
release of OXT and glutamate. We will test this hypothesis by using a combination of calcium imaging,
optogenetics, electrophysiology, and behavior to: (1) Determine whether the subpopulation of OXT neurons
activated by pain includes cells that project onto the SPNs, and whether those neurons specifically mediate
OXT’s effects on defensive behavior; (2) Quantify the individual contributions of OXT and co-transmitted
glutamate to SPN activation and behavioral sensitization during noxious experience; (3) Determine whether
differential coupling of glutamate and OXT release to spike frequency enables the OXT neurons to switch from
a simple, excitatory mode of activity to a stronger, modulatory mode at high stimulus intensities. These
experiments will show how the basic cellular and circuit properties of oxytocinergic neurons shape the
behavioral response to pain in a vertebrate model.

Public health relevance
Project Narrative Oxytocin, a neurotransmitter produced by neurons in the vertebrate hypothalamus, plays a central role in controlling the perception of and behavioral response to pan. This project will identify the neural circuit mechanisms that allow oxytocin-producing neurons to perform these functions. The results will improve our understanding of how the brain copes with painful experience.